IGF::OT::IGF 2015-E03B/OVARIAN CANCER CHEMOPREVENTION (SHETA2) PERIOD OF PERFORMANCE 09/24/2015 - 09/23/2017

This Task Order will address the hypothesis that NSC 721689 can prevent high-grade serous ovarian cancer via mortalin binding.